Preservation of Nonhuman Primate Spermatozoa by Lyophilization

PROJECT SUMMARY
The Oregon National Primate Research Center (ONPRC) is one of seven National Primate Research Centers
(NPRCs) sponsored by the NIH. It is supported by the P51 Core Grant (P51-OD011092) and provides the
expertise, technology, and resources required to deliver cutting-edge researchers access to nonhuman
primates (NHPs) for biomedical investigation. The ONPRC maintains a colony of approximately 4900 breeding
and research NHPs, the majority of which are rhesus macaques. Currently there is a national shortage of
rhesus monkeys available for research, which is constraining attempts to preserve animals that are genetic
carriers of rare or uncommon diseases. Successful preservation of gametes is a critical path forward to
ensuring access to these animal models for future research programs. Additionally, there has been a
tremendous shift in NHP model development from tissue-specific induced phenotypes in live animals to
induced disease-specific genotypes in single-cell embryos later used to derive adult animals. As these gene-
edited animals are difficult to achieve, preservation of gametes becomes a critical component to building
disease model cohorts. With an increasing emphasis on gamete preservation as part of NHP model programs,
alternatives to long-term gamete storage that does not require liquid nitrogen and costly storage or shipping
strategies have become the new focus in NHP assisted reproductive technology (ART).
In this supplement proposal to the parent grant, we will test the hypotheses that: 1) Modern freeze-drying (FD)
equipment and simplex optimization will deduce optimal conditions for lyophilizing fresh collected rhesus
macaque spermatozoa for long-term storage at common refrigeration temperatures; and 2) Spermatozoa
collected post-mortem from testis, epididymis, and vas deferens can undergo lyophilization and long-term
storage at common refrigeration temperatures for cynomolgus macaque, pigtailed macaque, baboon, and
marmoset species. To test these hypotheses, simplex optimization of FD medium will be performed using
previous published formulation attempts as a starting point. Elements such as medium components, pH,
freezing format, and drying times will be assessed by standard sperm quality assays already performed in the
ONPRC ART Core. Necropsy tissues from additional NHP species will be obtained from the Washington,
Texas, and Wisconsin NPRCs through their tissue distribution programs and evaluated for differences in tissue
origin lyophilization tolerance. Our findings will provide a benchmark for alternatives to NHP gamete storage
and establish a foundation from which to continue efforts to refine and maximize opportunities for preserving
valuable genetics.

Public health relevance
PROJECT NARRATIVE Cryopreservation of nonhuman primate (NHP) spermatozoa and long-term storage in liquid nitrogen is currently the only method utilized for preserving specimens with valuable genetics. These methods require skilled technicians to perform and costly storage vessels that are susceptible to damage and catastrophic sample loss. We propose to develop a standardized method of NHP semen freeze-drying (FD) that can be easily performed by most laboratory personnel and supports long-term storage at common refrigeration temperatures.